Breast Cancer Risk Factors and Epigenetic Age Acceleration

TECHNICAL ABSTRACT Cancer is the second leading cause of death in the United States, and breast cancer (BrCa) is the most diagnosed malignancy among women, and the second highest cause of cancer deaths. Despite lower overall incidence, African American (AA) women experience an earlier age of onset of BrCa and have significantly higher mortality rates compared to white women diagnosed with BrCa. Although screening, access and treatment may contribute to some of this disparity, it is clear that there are additional mechanisms underlying these disparities. New research suggests that racial differences in epigenetic profiles may be crucial for explaining inequalities of BrCa. Epidemiological studies have identified numerous factors associated with risk of developing BrCa. Hormonal factors, such as parity, age at first birth, age at menarche and oral contraceptive use, all have well established associations with BrCa risk. A number of other factors are also associated with BrCa risk, including body mass index (BMI), physical activity, family history, and specific genetic risk variants. However, additional research is needed to determine the underlying biological pathways of these well-established risk factors with BrCa risk. Interestingly, data in the literature suggests that effects of these risk factors differ by race, having smaller or larger effects on BrCa risk in AA populations compared to white populations. Epigenetic variants, including DNA methylation, are modifications to DNA that are both heritable and variable based on environmental variation. Epigenetic mechanisms thus may represent a link between genetic and environmental risk factors that underlie the development of BrCa, and also may explain racial differences in effect of risk factors for breast cancer. Two independent groups have recently identified that DNA methylation based on a handful of markers throughout the genome robustly predicts an individual’s chronological age and thus captures the “epigenetic clock” for biological aging. It has been shown that “epigenetic age acceleration” ? the difference between methylation-predicted age and chronological age ? is consistently associated with overall mortality and many age-related diseases including cancer. It has been further shown that epigenetic aging rates are significantly associated with race, sex, and with known cancer risk factors such as smoking and obesity, providing the first human evidence suggesting aging-related epigenetic processes are potential molecular underpinnings for racial health disparities. In this project, we will conduct a pilot project that will examine the impact of epigenetic age on the effect of known environmental and lifestyle risk factors for BrCa as it relates to breast cancer risk and then test to see if they differ by race. We will measure epigenetic age through methylation profiling of breast tissue and blood to evaluate (1) ability of blood epigenetic age to correlate with breast tissue epigenetic age; (2) assess differences by race and (3) to provide preliminary data on the correlation of breast epigenetic age with breast cancer risk factors. This proposal will provide the important preliminary data to expand this line of inquiry understanding environmental, genetic and epigenetic factors in BrCa carcinogenesis and BrCa disparities. The samples included in this project are from a large BrCa case-control study, and includes a socioeconomic status and racially diverse group of patients recruited from the Case CCC catchment area. This proposal will facilitate the generation of necessary pilot data for a larger R01 level grant to more fully study this important line of inquiry.

Public health relevance
PROJECT NARRATIVE African American women are less likely of being diagnosed with breast cancer compared to white women, but they have a greater risk of dying from the disease. This mortality difference may be explained by an earlier age of onset for breast cancer among African American women. Epigenetics measures the interaction between genetics and the environment and may provide a molecular underpinning for racial disparities in breast cancer. In this project, we will examine the impact of epigenetic age on the effect of known breast cancer environmental and lifestyle risk factors as it relates to breast cancer risk and then evaluate racially differences